Investigating the Immunosuppressive Function of lncRNA CRNDE in Hepatic Tumorigenesis

PROJECT SUMMARY/ABSTRACT
Hepatocellular carcinoma (HCC), a malignancy with compromised immune responses in tumor-infiltrating
lymphocytes (TILs), is an attractive target for immunotherapy. Studies have demonstrated that the inhibitory
immune-checkpoint signaling attributes notably to TIL dysfunction in HCC. Nevertheless, checkpoint blockade
treatments exhibited variable outcomes in HCC patients, as indicates the existence of additional mechanisms
underlying TIL dysfunction in HCC. Recently, lncRNAs have emerged as important messenger molecules for
intercellular communication between malignant cells and infiltrating immunocytes. Our preliminary data revealed
that HCC-derived lncRNA CRNDE is transferred into TIL via extracellular vesicle; the transferred CRNDE binds
to CypB protein, leading to decreased NFATc activity, TIL dysfunction, and eventually HCC immune evasion and
tumor progression. Based on preliminary data, our central hypothesis is that HCC-derived CRNDE promotes
tumor development and progression through prompting infiltrating immunocytes (e.g., TILs) dysfunction. The
overall objectives of this proposed study are 1) to elucidate the molecular mechanisms by which HCC-derived
CRNDE inhibits the anti-tumor immune response of TILs and promotes tumor growth; and 2) to determine the in
vivo anti-HCC efficacy of CRNDE inhibition in mouse models. We propose three specific aims to test the central
hypothesis and address these highly relevant objectives. In Aim1, the functional impacts of HCC-derived CRNDE
on tumor infiltrating immunocytes and tumor progression will be studied by using complementary mouse models.
Additionally, ELISpots, FACS, scRNA-seq and other newly-developed methods will be employed to analyze the
isolated TILs from mouse models. In Aim2, the specified molecular mechanisms underlying CRNDE-mediated
TIL dysfunction will be delineated. Various biochemistry and molecular biology techniques will be employed to
scrutinize the detail interaction of CRNDE-CypB, as well as its functional effects on NFATc signaling in TILs. In
Aim3, the anti-HCC efficacy of CRNDE-specific LNA gapmer-ASOs and its potential synergic effectiveness with
checkpoint blockades will be evaluated by using two complementary mouse HCC models. Given CypB is one of
the key targets of immunosuppressants Cyclosporine and FK506/Tacrolimus, this study is highly significant as
it is expected to uncover a previously unrecognized mechanism of CypB regulation in the setting of HCC immune
evasion. The proposed study is innovative, as it is expected to define a conceptually novel model of HCC
immune evasion and to develop a new approach for HCC immunotherapy. At the completion of the proposed
study, our expected outcomes are to have defined the mechanisms by which HCC-derived CRNDE suppresses
the immune responses of TILs in HCC microenvironments; we also expect to have demonstrated the in vivo anti-
HCC efficacy of CRNDE-specific LNA gapmer-ASOs. These results are expected to have an important positive
impact on the development of new immunotherapeutic approaches to treat cancer; they will also provide a strong
evidence-based proof of principle for further development of ASOs-based therapeutic strategy.

Public health relevance
PROJECT NARRATIVE Hepatocellular carcinoma (HCC) is the fifth most common cancer and the third leading cause of cancer- related death worldwide. The incidence and mortality of HCC continues to increase both in the United States and around the world, but current treatment options for HCC remain unsatisfactory. This project will study a crucial molecular that has the potential to modulate the immune cell activity in HCC, which will lead to the development of new immunotherapeutic strategies for future effective treatment of liver cancer.